Evaluation and Optimization of a Just-in-Time Messaging Intervention to Reduce Alcohol-Facilitated Intimate Partner Violence Perpetration Among At-Risk Young Adult Men and Women

PROJECT SUMMARY
Young adult men and women perpetrate intimate partner violence (IPV) at high rates. A summary of over 30
years of research concludes that alcohol is a causal factor of IPV, particularly acute alcohol intoxication,
highlighting the critical need for interventions delivered proximally to drinking episodes – a period of increased
risk for IPV. Yet despite the high societal and personal costs associated with heavy drinking and IPV and the
high prevalence of alcohol facilitated IPV, empirically supported interventions are lacking, particularly those
that are low resource and easily scalable for wide dissemination. It is increasingly feasible to deliver Just-In-
Time (JIT) interventions via mobile technology, particularly those that adapt over time to an individual's
changing needs to provide appropriate intervention strategies based on real time, real world context – Just-In-
Time Adaptive Interventions (JITAIs). JITAIs have been evaluated for a range of behavioral health issues
including alcohol use; however, no empirically supported JITAIs for alcohol-facilitated IPV perpetration exist.
To develop JITAIs, JIT interventions are optimized through innovative micro-randomized trials (MRTs) in which
individuals are micro-randomized to receive different intervention strategies at critical time points to determine
when a message is best delivered, which type of message is most impactful for whom, and under what
conditions. Thus, the present application will combine a traditional RCT to evaluate the efficacy of delivering
JIT messages to reduce alcohol facilitated IPV perpetration with a MRT to optimize the selection and
adaptation of messages for a future JITAI. The proposed intervention focuses on theoretically and empirically
supported targets for IPV perpetration consistent with the I3 Model – the prevailing unifying theory of IPV
perpetration – including distress tolerance skills, emotion regulation skills, and alcohol reduction strategies. An
RCT by the PI (K08AA021745) supports these intervention targets for reducing alcohol use and IPV
perpetration among women with sexual assault histories, and a recent pilot study supports the feasibility and
acceptability of delivering these JIT messages using a MRT design to at-risk men and women with good
effects of the intervention on key alcohol and IPV outcomes. As such, we propose to evaluate the efficacy of
this JIT messaging intervention in 400 heavy drinking young adults with recent IPV perpetration. Participants
will be randomized to the JIT messaging intervention or an assessment only control (RCT design). All
participants will complete a baseline survey, 30-days of twice daily monitoring, and 1-, 3-, and 6-month follow-
up surveys. Within the intervention arm (MRT design), individuals will be micro-randomized after each morning
and evening report during the 30 days of monitoring to (1) receive a JIT message or not, and (2) if yes, to one
of three message types (distress tolerance skill, ER skill, alcohol reduction strategy). This innovative design will
optimize the selection and adaptation of JIT messages for a future JITAI to reduce alcohol facilitated IPV.

Public health relevance
PROJECT NARRATIVE Acute alcohol intoxication is a robust predictor of intimate partner violence (IPV) perpetration for young adult men and women; therefore, interventions delivered proximally to drinking episodes – a period of high risk – are needed to reduce alcohol-facilitated IPV. This project seeks to improve public health by delivering a just-in-time text messaging intervention proximally to drinking episodes and evaluating the impact of the intervention on alcohol-facilitated IPV in a sample of at-risk young adult men and women. Additionally, through an innovative design this project is poised to answer these important questions: whether receiving a message, when, for whom, what type, and under what conditions this just-in-time messaging intervention leads to reductions in alcohol use and IPV perpetration.